KGP Hamilton NGS STAR

Project Summary
The Keck Genomics Platform (KGP) at the University of Southern California (USC) seeks to acquire, install,
and integrate the Hamilton NGS STAR automated liquid handling system to revolutionize our Next Generation
Sequencing (NGS) operations. This state-of-the-art system will significantly improve the efficiency and
throughput of our NGS library preparation processes, addressing critical bottlenecks in our current workflow.
By implementing the Hamilton NGS STAR, we aim to streamline sample preparation, reducing hands-on time
and minimizing manual errors, while enhancing reproducibility across diverse NGS applications. The system
will increase our capacity to handle larger batch sizes and more complex protocols, optimizing reagent usage
and reducing waste through precise liquid handling.
The automation provided by the NGS STAR will allow us to reduce overall costs associated with library
preparation and decrease turnaround times for sequencing projects. This efficiency gain will enable us to
expand our service offerings to include more sophisticated NGS applications at a lower price, attracting a
broader customer base and facilitating cutting-edge research across USC and beyond. The system's flexibility,
enabled by the Hamilton System Language (HSL) and VENUS software, will allow us to develop and
implement custom protocols, further expanding KGP's capabilities.
By investing in the Hamilton NGS STAR, KGP will strengthen its position as a leading genomics core facility,
supporting innovative research and fostering scientific discoveries at USC. This upgrade aligns with our
commitment to providing top-tier sequencing services and will significantly contribute to advancing genomics
research in our academic community.

Public health relevance
Project Narrative USC's Keck Genomics Platform aims to acquire the Hamilton NGS STAR system to automate and enhance our NGS (Next Generation Sequencing) library preparation operations. This upgrade will improve efficiency, reduce costs, and expand our genomics research capabilities. By enhancing consistency and reproducibility, increasing throughput and enabling complex workflows, we'll attract more researchers and strengthen USC's position in biomedical research.